Administrative & Mentoring (A&M) Core

PROJECT SUMMARY/ABSTRACT
Core – Administrative and Mentoring Core
The Administrative and Mentoring Core (A&M Core) is focused on supporting the successful operation of the
Center for Rural Health Care Delivery Science. The Center represents a multidsciplinary and community-
engaged research program that unifies existing expertise and develops a transformational team-based
approach to studying and improving rural health care. The goal of the A&M Core is to provide leadership and
general administrative support for researchers, mentors, research cores, and advisory committees, including
project management, timely communications, financial management, and attention to rigorous evaluation and
oversight processes (Aim 1). A critical focus of the A&M Core is on overseeing the mentorship and
development of Research Project Leaders, including support necessary for successful transition to
independence (Aim 2). Further, to assure sustainability of the COBRE, this core will also facilitate the
development and growth of early-career clinician-scientists focused on rural health care delivery science
through support of new faculty recruitment and development of a competitive pilot project funding mechanism
(Aim 3). COBRE funding, coupled with substantial institutional funding and a commitment to hire five additional
faculty members during Phase I, will provide an outstanding foundation for the development of a vibrant Center
with a strong nucleus of independently funded faculty members.The A&M Core will be supported by a Steering
Committee and an Evaluation Committee, and advised by an Internal Advisory Committee and External
Advisory Committee.